DENGUE FEVER AND OTHER INFECTIONS IN THE AIDS ERA

The Thai Ministry of Public Health has, since the 1970's, collected data on 52 reportable diseases, of which dengue hemorrhagic fever/dengue shock syndrome (DHS/DSS) is one. This disease has increased in incidence (180,000 cases reported in 1987), and the age distribution appears to have shifted from primarily children to also include older persons. HIV infection is widespread, particularly in the northern region. The intention is to analyze these data by age, region, rural-urban differences, climatic data and the predominance of virus type (1,2,3 or 4) by year. Birth cohort analysis will be included. Interaction of HIV and DHF/DSS will be sought in the northern region.